Research and Methods Core

The Research and Methods Core within our proposed Center for Transformative Community-driven Research to Prevent Obesity-related Cancer (the Center) will serve as a comprehensive, multilateral research and evaluation resource to all core directors, project leaders, trainees engaged in the Career Enhancement Core, and awardees of the Developmental Core. Services will include hypothesis refinement, design of clinical and basic science experiments, data acquisition and management, development and application of innovative and state-of-the-art statistical methodology, biostatistical and geospatial analyses, data interpretation, and publication of results generated by the Center through abstracts, papers, and presentations. We will work with all projects and cores in performing the required quantitative and qualitative analyses, archiving data sets
and analysis scripts to ensure the reproducibility of analyses and ensure proper interpretation of all results.
We will identify and incorporate into all the research and pilot projects the adoption of consistent design(s),
contextual and outcome measures relevant to the research in persistent poverty census tracts. Our Research
and Methods Core team participated in the development of each research project, properly designing studies
to achieve the stated scientific aims. We will meet regularly with project leaders to discuss each project's data processing and analysis needs. The members of this Core are experienced in managing and integrating standard and innovative data types that ensure consistent and compatible data handling. By providing research expertise and logistic support to data analytic activities within each project, the Research and Methods Core will contribute to the professional, ethical, efficient, and rigorous use of the data generated by each project.

Public health relevance
The Research and Methods Core within our proposed Center for Transformative Community-driven Research to Prevent Obesity-related Cancer (the Center) will serve as a comprehensive, multilateral research and evaluation resource to all core directors, project leaders, trainees engaged in the Career Enhancement Core, and awardees of the Developmental Core. Services will include hypothesis refinement, design of clinical and basic science experiments, data acquisition and management, development and application of innovative and state-of-the-art statistical methodology, biostatistical and geospatial analyses, data interpretation, and publication of results generated by the Center through abstracts, papers, and presentations.